Longitudinal Assessment of Eating-related Anxiety in Anorexia Nervosa

Project Summary. Anorexia nervosa (AN) is a behavioral disorder marked by self-starvation and fear of weight
gain. Weight restoration to a BMI of 19-21 remains the mainstay of treatment for severe AN despite relapse rates
in the first year of up to 50%. The mechanisms underlying these high relapse rates remain unknown. Meal-
associated anxiety is a striking feature in patients with AN. As the disorder develops, eating behaviors are in-
creasingly driven by what appears to be a conditioned avoidance of energy dense foods, known as fear foods,
suggesting that exposure-based approaches to treatment may help drive remission. However, in many intensive
treatment programs, tube feeding over meal-based nutrition is increasingly the approach. Thus, the need is
great for determining what mechanisms and approaches underly the successful treatment of AN and
what neurobehavioral factors render individuals responsive versus resistant to treatment. Research: Ex-
periments will address the extent to which habituation of learned aversions to fear foods following meal-based
exposure generalizes across similar types of foods (Aim 1). Task-based fMRI combined with this behavioral
approach will allow the determination of the neural substrates of habituated anxiety responses (Aim 2a). Finally,
a machine-learning approach will be used to predict anxiety ratings based on baseline neural activation and
identify individuals responsive vs resistant to treatment (Aim 2b). By demonstrating the significance of addressing
food-related anxiety as a primary treatment target and examining the neural circuitry activated by fear foods, this
project has potential to 1) alter how AN is treated across multiple levels of care and social eating settings, and
2) enhance understanding of the neurobiology that sustains treatment refractoriness. Career Development: The
training plan will provide the PI with a) clinically relevant training in the phenomenology of AN, clinical course,
and validated instruments used to assess eating disorders important to formulating clinically relevant hypotheses
and data interpretation, b) hands-on training in advanced statistical methods for fMRI data, c) opportunity to
integrate her training in factors that influence food choice with obtained results, and d) training in grant writing
and career development to launch an independent research career. Environment: Johns Hopkins is an excellent
environment for collaborative, interdisciplinary, and translational research in healthy and disease states and is
focused on mentoring junior faculty. The Johns Hopkins Hospital is ranked #1 in the nation for Psychiatry, with
the School of Medicine being the leading research medical institution in the United States and the Eating Disorder
Program nationally recognized as a leading program for eating disorder treatment. Career Goal: The proposed
research and training program is targeted to meet the PI's overall career goal of becoming an independent
academic researcher investigating the biological basis of eating disorders at a university setting by providing the
skills and pilot data necessary for larger R01 proposals to examine neural mechanisms underlying the driven
nature of eating disorder behaviors with the goal of improving existing treatments and personalizing care.

Public health relevance
The proposed project has significant public health relevance; nearly 30 million Americans will have an eating disorder in their lifetime. These disorders are increasingly recognized to have a biological basis, however neural mechanisms and factors that render individuals responsive vs resistant to treatment, recovery, and remission are poorly understood. This project will characterize behavioral factors and brain mechanisms underlying food choice, associated eating-associated anxiety, and striking clinical features of anorexia nervosa and determine their relationship to treatment responsivity.